Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories

Connecticut Department of Public Health State Laboratory Project Summary: Maintenance and Enhancement of ISO/IEC 17025:2005 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories RFA-FD-17-010 The Connecticut State Public Health Laboratory (CTSPHL) has applied (submitted an application) for and been audited by the AIHA-LAP, LLC for ISO/IEC 17025:2005 (ISO) accreditation for the microbiological examination of produce by its food testing section. The CTSPHL is seeking this grant award in order to aid in maintaining the Laboratory’s ISO accreditation. The grant award would allow the Laboratory to: 1) Maintain the personnel and procedures needed for the microbiological examination of produce in accordance with ISO requirements; 2) Offset associated costs for inspections/ audits by ISO accrediting bodies, and 3) Offset the extra costs associated with equipment maintenance/calibration and laboratory supplies associated with the ISO requirements. The CTSPHL is only seeking an award under Competition A of RFA-FD-17-010 As part of the requirements for this grant, the CTSPHL has partnered with the Connecticut Department of Consumer Protection (DCP), the state agency responsible for regulation of MFRPS. DCP will be responsible for the collection of samples and submitting these to the CTSPHL for testing. A letter from DCP is included in this application expressing their commitment to the project. Additionally DCP holds a contract for food safety inspections with FDA. The CTSPHL is currently in the FERN/FSIS program (Cooperative Agreement Number: FSIS-C-06-16) and participates in both the chemistry and microbiology proficiency test challenges as well as some drills. The CTSPHL currently uploads all its food testing results for pathogens into eLEXNET, including both results associated with its current FDA Food Testing/ ISO Accreditation (e.g. routine surveillance) and any other food testing results for pathogens. This practice will continue. In order to achieve the requirements of this grant the CTSPHL plans on the following: 1) Increasing the number of samples tested to at least 75/year. 2) Increase the scope of testing by adding shiga toxin producing e. coli (STEC) to our scope of accredited methods

Public health relevance
Connecticut Department of Public Health State Laboratory Project Narrative: Maintenance and Enhancement of ISO/IEC 17025:2005 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories RFA-FD-17-010 Background: The Connecticut State Public Health Laboratory (CTSPHL) is applying for an award under Competition A of RFA-FD-17-010. The CTSPHL is currently in Year 5 of the Attainment of ISO/IEC 17025:2005 Accreditation for Testing Foods for Microbiology grant initially awarded in September 2012. The CTSPHL applied for ISO/IEC 17025:2005 (ISO) accreditation in January of 2017 and was audited by the Laboratory’s chosen accrediting body, AIHA-LAP, LLC, in March of 2017. The CTSPHL has corrected the deficiencies found in the audit and made its initial response to the audit findings. Accreditation is expected to be achieved before the current grant expires (08/31/2017). Maintaining ISO/IEC 17025:2005 Accreditation: The Laboratory will maintain its accreditation for food testing. Based on the results of the initial audit, the Laboratory feels the findings were of a minor nature, and that the corrective actions put in place will satisfy the ISO requirements. In order to maintain accreditation for year 1, the CTSPHL will participate in the AOAC PT Sample Program, as it has for the last 4 years, and follow the ISO requirements for internal inspections and training. Increasing the Number of Food Samples Analyzed Annually: The Connecticut Department of Consumer Protection (DCP) is the State agency that is enrolled in the MFRPS. The DCP and the CTSPHL will work collaboratively to collect and analyze food samples over the grant period The collaborative effort will be to collect and analyze 8-10 samples per month for routine surveillance. In the event of a food emergency this number may increase depending on the circumstances. Currently the number of samples collected and analyzed is 4/month, therefore this will effectively double the number of samples analyzed. Enhancement of Scope of Testing: The CTSPHL currently performs presence/absence testing for three organisms in produce: Listeria monocytogenes, Salmonella, and Escherichia coli O157:H7. The CTSPHL proposes adding presence/absence testing for shiga toxin producing e. coli (STEC) to broaden its scope of testing. The CTSPHL would develop and validate the procedure in the initial year of the grant and implement routine surveillance in year 2. The Environmental Microbiology Laboratory will follow the Food and Drug Administration Bacteriological Analytical Manual (FDA BAM) methodology for the detection and recovery of non-O157 Shiga toxin-producing Escherichia coli (STEC). The enrichment procedure and real-time PCR screening assay validated for E.coli O157 in FDA BAM is also validated for other non-O157 STEC. The FDA BAM isolation and confirmation procedures for non-O157 STEC will be followed including adding additional media, L-EMB agar for isolation and performing Polymerase Chain Reaction (PCR) on isolates to confirm toxigenic potential. Further characterization of positive non-O157 STEC isolates will be performed using whole genome sequencing.